Research Education Component

Project Summary: SAGE Research Education Component
The goal of the SAGE Research Education Component is to enhance the diversity of the aging research workforce by
mentoring promising scientists from under-represented groups for sustained careers in aging research. Through an annual
pilot award program, we seek to advance the academic career trajectory of junior faculty and postdoctoral fellows from
under-represented groups (collectively “SAGE Scientists”) from Stanford University and our affiliated organizations by
providing training opportunities, mentoring and support to enable them conduct trans-disciplinary, research that
integrates biological, social and behavioral sciences aspects using emerging methodologies (biomedical data
science, digital health methods, precision medicine techniques and virtual reality and simulation based
interventions). Each year, the SAGE program will fund three pilot awards. As a show of strong institution support, two
additional pilot awards will be supported by Stanford School of Medicine. The training period for SAGE Scientists
through the RCMAR program is one year. The components of their training experience will include didactic instruction
specifically designed to impart knowledge about research methodologies and health disparities embedded within a
degree or a customized selection of courses that enhance knowledge in domains important for future success. All SAGE
Scientists will complete a mentored pilot research project focused on integrating biological, social and behavioral sciences
on emerging methodologies in aging research, designed and implemented with the guidance of committed, and skilled
research mentors. Each SAGE Scientist will be assigned a research mentor (typically an expert in biomedical data science,
digital health methods, precision medicine techniques and virtual reality and simulation based interventions) and a
methods mentor (typically a behavioral scientist, epidemiologist, statistician, or informatician). To complement this
independent research training, SAGE Scientists will attend a weekly seminar series that includes scholar research-in-
progress, faculty research, professional guidance, peer to peer advising, and professional development topics.
Additionally, they will complete training in research ethics, research reproducibility, compliance, and good clinical
science practices. At the completion of their training, the SAGE Scientists will have acquired much of the knowledge,
skills, and attitudes necessary to transition into viable academic careers. These skills include conducting trans-disciplinary
aging research, authoring manuscripts, competing for external funding, developing mentoring and team building
strategies, and understanding how to design and implement their career development plans. We aim to enable our SAGE
Scientists to successfully step into research-based positions in academia, industry, government, or the not-for-profit
sector. SAGE Scientists will learn in an environment that emphasizes teamwork and teaches that the most innovative
research is a product of team-science that bridges all disciplinary areas spanning the aging landscape, from the
identification and mitigation of health disparities to discovery of novel approaches that promote health equity and
wellness for diverse older Americans.
!